IGF::OT::IGF SPECIAL STUDIES/ANALYSIS- CHEMICAL/BIOLOGICAL

Indenos for Injection Clinical Lot. This agent is being developed in support of ongoing Phase I/2 clinical trials at several institutions. These supplies are needed to support these human clinical trials.